Pilot Project Program

Abstract: The Pilot Project Program of the Environmental Health Sciences Center (EHSC) is key to multiple
goals of the Center, including: establishing and developing new and novel research to expand translational
environmental health sciences, supporting career development, attracting new Center members, strengthening
existing areas of Center research, and promoting engagement between researchers and community partners to
address identified needs. Two types of pilot project awards are offered on a bi-annual basis: Full Pilot Projects
of up to $30K, and Mini Pilot Projects of up to $10K. Pilot Project applications are reviewed by a Standing Review
Committee comprised of Center members with expertise ranging from epidemiology to basic science research.
This committee includes both junior and senior faculty, the Director of Career Development Program and
members with overlapping roles in the Clinical and Translational Sciences Institute at the University of Rochester
Medical Center (URMC). When necessary, additional reviewers from within or outside of URMC faculty serve as
ad hoc members, providing additional relevant expertise or to alleviate conflicts of interest. The Community
Engagement Core (CEC) and Integrated Health Sciences Facilities Core (IHSFC) foster research-community
partnerships that may lead to Pilot Project proposals that are responsive to community concerns and
opportunities. The Biostatistics Core provides consultation on Pilot Project study design and data analyses. All
applications are read by the Director of the CEC, who works with PIs to enhance community engagement in
ongoing research directions. Since the start of the current funding cycle, a total 48 Full Pilot Project applications
and 29 Mini-Pilot applications were received. Of these, a total of 29 Full and 22 Mini-Pilot Projects have been
awarded. Of the 51 applications that were awarded,15 were to junior faculty investigators, and 15 were awarded
to non-Center members, of whom 7 have since become Center members. During the current funding cycle,
approximately $993K has been allocated to Pilot Projects (both Full and Mini-pilots), which has resulted in
approximately $15M (direct cost dollars) in new extramural funding. This is a notable return given not only the
present extremely limited funding environment, but also considering that the most recently awarded pilot projects
have not yet had sufficient time to mature into externally funded projects. Future directions include continuation
of the Pilot Project Program to build new and strengthen existing areas of Center interdisciplinary and
translational research, foster junior faculty career development, attract new Center members, and engage
community partners. In addition, the Pilot Project Program plans to continue to lead and participate in new
collaborative pilot projects with other NIEHS P30 Centers across the country.